Development Genetics of Tooth Number Variation in Sticklebacks

Project Summary
The long-term goal of this project is to identify the genetic circuitry regulating tooth formation and replacement.
As 30 percent of people worldwide over the age of 65 have no natural teeth, understanding how teeth
regenerate is a major goal in biology. Furthermore, teeth, like most organs, form through repeated reciprocal
signaling between epithelia and mesenchyme. Thus, understanding the genetic basis of tooth formation and
replacement is important both for understanding organogenesis in general, as well as for understanding how
teeth can be regenerated in vitro and ultimately in vivo. Teeth are homologous to other vertebrate skin
appendages including mammalian hair, and shared genes regulate both tooth and hair formation. Although
genetic studies in humans, mice and other vertebrates have identified signaling pathways involved in tooth
formation, less is known about how genes regulate tooth replacement. In contrast, how genes regulate
mammalian hair regeneration is much more understood. One parsimonious hypothesis is that teeth and hair
regenerate using similar genetic circuits. Fish retain the ancestral jawed vertebrate condition of constant tooth
replacement throughout adult life. Fish also fertilize their offspring externally in large numbers, providing
powerful systems for developmental biology and genetic analyses. Threespine stickleback fish (Gasterosteus
aculeatus) offer a new and powerful system to learn the genetic basis of tooth formation and replacement.
Relative to low-toothed marine ancestors, derived freshwater populations evolve major heritable increases in
tooth number and tooth replacement rates. The different forms can be crossed in the lab, enabling detailed and
unbiased forward genetic analyses to map factors controlling the changes in tooth number. Genetic and
genomic experiments have mapped one genomic region controlling tooth number to a cis-regulatory intronic
tooth enhancer of the Bone Morphogenetic Protein 6 (Bmp6) gene in one high-toothed population. Relative to
the marine enhancer, the freshwater enhancer displays expanded tooth epithelial expression, and reduced
tooth mesenchymal expression, suggesting these spatial shifts in enhancer activity underlie evolved increases
in tooth number. Furthermore, in mice, BMP signaling negatively regulates hair regeneration, and in fish BMP
signaling negatively regulates tooth replacement. Together these data support the hypothesis of shared
genetic circuitry regulating tooth and hair regeneration. To test this hypothesis, three specific aims are
proposed. First, transgenic and genome editing experiments will determine which mutations in the freshwater
Bmp6 enhancer affect expression differences and tooth number. Second, genome editing experiments will
determine Wnt ligand function during tooth formation and replacement. Third, vital dye pulse-chase
experiments will test whether tooth replacement is coordinated within a tooth field. Together these aims will
reveal fundamental knowledge of the developmental genetic circuitry regulating tooth formation and
replacement, and provide further tests of the hypothesis that teeth regenerate similar to mammalian hair.

Public health relevance
Project Narrative PUBLIC HEALTH RELEVANCE: This research will provide basic insight into how genes control tooth formation and tooth replacement. This knowledge will help efforts to engineer tooth formation in vitro and ultimately regenerate teeth in vivo, as well as provide fundamental knowledge of vertebrate organ regeneration.